Transcriptomic Changes during early endometriotic lesion development

PROJECT SUMMARY
Endometriosis is a non-malignant disorder defined by the presence of endometrial-like tissue outside the uterus
and is associated with debilitating pelvic pain and impaired fertility. Retrograde menstruation is a primary etiologic
pathway. The on-average 7-10 years between the onset of symptoms and definitive diagnosis of endometriosis
places an enormous emotional and financial burden on both the patient and the healthcare system. Despite the
significant health care costs and long-term health risks associated with endometriosis, its molecular etiology
remains largely unknown, and non-invasive diagnostic and non-hormonal treatment options remain elusive.
Therefore, a critical need exists to understand the pathogenesis of endometriotic lesions, which will ultimately
lead to early treatment interventions and prevention of disease progression. Although, most studies on
endometriosis have focused only on adults, patients with endometriosis report that their pain symptoms emerged
during adolescence and young adulthood. Our baboon model has provided significant insight into the early
pathophysiology of the disease and the mechanisms associated with aberrant gene expression. Furthermore,
the peritoneal disease induced in our baboon model phenocopies changes associated with endometriosis in
women including transcriptomic changes in the eutopic endometrium and lesion gene expression. Therefore, the
Specific Aims of this proposal are to integrate single cell, spatial, and bulk transcriptomics analyses of peritoneal
endometriotic lesions at 12 months after the induction of disease in the baboon and explore translation of these
discoveries to human adolescents at early stages of endometriosis. Specifically, in Aim 1 we will determine the
early inflammatory transcriptomic events in peritoneal endometriotic lesions by single cell and spatial
transcriptomics analyses in our baboon model at 12 months of disease and correlate these changes with spatial
transcriptomics analysis of endometriotic lesions from adolescent patients with endometriosis at 12-months post-
onset of symptoms. In Aim 2 we propose to identify new drug candidates using Reversal of Gene Expression
Score (RGES) to compute a drug’s potency to reverse disease gene expression based on bulk RNA-seq gene
expression signatures from baboon lesions and human superficial peritoneal lesions from adolescent patients
within 12 months since onset of symptoms. Drugs, filtered to target cells/pathways identified as pathologically
relevant, will be tested in an endometriotic spheroid model of invasion followed by RNA-sequencing of spheroid
epithelium to validate the mechanism of action. Successful completion of this research project will identify the
key inflammatory transcriptomic changes over time in endometriotic lesions during their early developmental
timepoints and will pave the way for early biomarker discovery, and identification of drugs for targeted therapies,
which will be of direct relevance to the early disease identification and treatment for women with endometriosis.

Public health relevance
PROJECT NARRATIVE Despite affecting over 190 million women worldwide and being recognized for over a century, our understanding of endometriosis pathogenesis remains limited. The proposed research will leverage cutting-edge transcriptomic approaches to identify cellular signaling and molecular mechanisms in early lesions. By integrating molecular data from baboon and human peritoneal lesions and applying advanced computational analyses, we will uncover key inflammatory pathways, leading to novel therapeutic targets and advancing precision medicine for superficial peritoneal endometriosis.